Single Cell Encoding of Cocaine Seeking Behavior in the Nucleus Accumbens

ABSTRACT
Drug addiction, including cocaine-abuse disorder, represents a major public health issue, characterized by
compulsive drug seeking and increased propensity to relapse after abstinence. Relapse to cocaine seeking is
triggered by environmental cues strongly associated with the rewarding effects of the drug itself. The neuronal
encoding of cocaine-associated cues at a single-cell level remains unclear, limiting our understanding of how
cocaine-paired cues trigger drug seeking behavior. Via its constituent dopamine D1- and D2- receptor expressing
medium spiny projection neurons (MSNs), the nucleus accumbens core (NAcore) plays a key role in encoding
cue-reward associations and triggering relapse to cocaine seeking behavior. The NAcore integrates multiple
cortical and allocortical inputs. In particular, the activation of afferent glutamatergic projections from the prelimbic
cortex (PL) are necessary for cue-induced reinstatement of cocaine seeking. Using chemogenetic and
optogenetic manipulations on D1- and D2-MSNs, previous studies have shown opposite roles of these neuronal
subtypes on cue-induced reinstatement of cocaine seeking in rodent models of self-administration. Therefore, I
hypothesize that cocaine seeking during context/cue-reinstatement and refraining from seeking during extinction
training are associated with temporally and spatially distinct neuronal ensembles of D1- and D2-MSNs that are
differentially modulated by PL-NAcore projections. I will address this hypothesis by quantifying Ca2+ activity in
D1-MSNs (Aim 1) and D2-MSNs (Aim 2) during cocaine-seeking and extinction, with and without inhibiting PL-
efferents to NAcore. To investigate the functional role of D1- and D2-MSNs during cocaine seeking, we will
record single-cell Ca2+ dynamics from D1- and D2-MSNs using a head-mounted miniature microscope and virally
expressed Cre-dependent Ca2+ indicator (GCaMP6f) in D1- and D2-cre transgenic mice while undergoing
cocaine self-administration, extinction training and cue-induced reinstatement, We will further inhibit PL-NAcore
projections during drug seeking tests (post abstinence and during cue-induced reinstatement) using virally
expressed inhibitory Gi-DREADDs. Recorded Ca2+ dynamics will be analyzed using advanced statistical models
and clustered to isolate the neuronal ensembles associated with context/cue-induced drug seeking and refraining
from seeking during extinction. The information obtained from this research will isolate neuronal ensembles that
encode cocaine-seeking, as well as the mechanism(s) by which PL-NAcore projections affect these ensembles
to regulate cue-induced reinstatement. This fellowship will train me in experimental design, scientific writing, and
cutting-edge techniques to understand the brain circuits underlying drug addiction, including viral transfection
and micro-endoscopic analysis of Ca2+ activity in transgenic mice trained to self-administer and reinstate to drug-
associated cues and contexts.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Drug addiction is a major public health concern, mainly characterized by high vulnerability to relapse despite sustained periods of recovery. The proposed experiments will characterize the mechanisms by which neuronal ensembles within the nucleus accumbens, a neural substrate for reward seeking and motivated behavior in the brain, encode cocaine seeking behavior and extinction training, in response to cocaine-associated context/cues. Knowledge gained from these studies will broaden our understanding on the circuitry coding drug-associated rewards, and therefore advance our fundamental understanding to the pathological neuroadaptations in the context of drug addiction.